BCM CENTER FOR PRECISION MEDICINE MODELS

1. ABSTRACT - Overall
The introduction of clinical exome sequencing, whole genome sequencing, RNA sequencing, and metabolomics
has transformed our ability to diagnose patients with suspected genetic disease. With the introduction of these
technologies, a potential molecular DNA lesion can be identified in at least 30% of patients with a suspected
genetic diagnosis. These technologies have led to the discovery of thousands of new disease genes and to
phenotypic expansion within known genetic diagnoses. This continued discovery of new disease genes leads to
mechanistic studies that assist personalized approaches for management and therapy. However, up to 70% of
patients with suspected genetic disease remain undiagnosed likely because their disease-causing variant(s)
have yet to be discovered or the clinical significance of identified variants is unclear. Critically, even when genetic
testing is diagnostic, 90-95% of rare genetic disorders have no therapy. Precision models produced using various
genome modification techniques in Drosophila melanogaster (fly) and Mus musculus (mouse) are important tools
aiding in the interpretation of these variants of uncertain clinical significance and are critical for testing therapeutic
paradigms. The Center for Precision Medicine Models (CPMM) was established to aid researchers, clinicians,
genetic counselors, patients, and family organizations in the study of precision animal models of undiagnosed,
rare, and Mendelian diseases. Our goal has been to use our models to end the diagnostic odyssey and advance
personalized medicine approaches for the millions of people around the world affected by rare genetic diseases.
To achieve this goal, CPMM has generated and phenotyped precision fly and mouse models of human disease-
associated genetic variants submitted by the rare disease community. CPMM has received 124 submissions for
modeling, encompassing 175 unique variants in 120 different genes, and accepted 52 nominations involving 68
variants in 51 genes. Our modeling has contributed to the discovery of new disease genes and phenotypic
expansion and is testing new treatment strategies. We propose to continue and expand our efforts by pursing
the following aims: (1) Leverage existing multidisciplinary expertise harnessed by the CPMM and use cutting-
edge genome modification and phenotyping approaches to generate and characterize precision animal models
that answer clinical questions with impact on patient care; (2) Engage human genome discovery programs,
including those that focus on populations underrepresented in research, as well as clinicians, researchers,
families, and patient organizations to recruit disease-associated variant nominations for precision model studies
within the Center; (3) Perform bidirectional translation of findings from precision animal models and patient
clinical studies for integration into clinical diagnostics, clinical care, or clinical trials; (4) Enhance and develop
new bioinformatics platforms that optimize Center disease modeling and organizational activities. Although the
focus of CPMM builds on our expertise in undiagnosed, and rare Mendelian diseases, our long-term goal is to
broaden our scope by modeling multigenic and common diseases.

Public health relevance
The introduction of clinical exome sequencing and whole genome sequencing has transformed our ability to diagnose patients with suspected genetic disease. However, up to 50-70% of patients with suspected genetic disease remain undiagnosed likely because their disease- causing variant(s) has yet to be discovered, or the clinical significance of variants identified in genomic studies remains unclear. The BCM Center for Precision Medicine Models will support local, national, and international programs and individual researchers in the development of precision animal models that end the diagnostic odyssey of patients with undiagnosed, rare, and Mendelian diseases and serve as resources for pre-clinical studies investigating personalized medicine approaches to their care.